Probing the Effects of Pathological Conditions on AKT

Project Summary
The PI3K-AKT pathway is one of the most implicated pathways in disease. AKT is the main regulator of the
pathway through its interactions with over one hundred protein partners to accomplish specific cellular outcomes
including cell proliferation, survival, metabolism, and protein synthesis. To accomplish these cellular outcomes,
AKT must first undergo a conformational change in the cytoplasm towards an active conformation, then associate
at the plasma membrane, and finally interact with its binding partners. Despite its prominent role in major cellular
functions and knowledge of AKT’s activation process, real time mechanistic information regarding how AKT
becomes active, associates at the plasma membrane, and interacts with its binding partners under physiological
and pathological conditions is not well understood. We hypothesize that biophysical differences in each of these
steps of AKT’s activation process underlie pathway dysregulation in disease. Knowing this information is critical
to understand the basic biology of the pathway under physiological and pathological conditions,
characterize/reveal important kinetic vulnerabilities associated with AKT conformational bias/membrane
association, and identify AKT-protein partner complexes that can be exploited in the long-term to treat disease.
To interrogate this hypothesis, we have developed novel live-cell bioluminescent- and bioluminescence
resonance energy transfer-based assays that will be applied to measure how 1) conformational changes and
membrane association, and 2) populations of AKT-protein partner complexes vary between physiological and
pathological conditions. These approaches overcome major limitations associated with studying purified protein
and complex results from standard cell-based viability and signaling assays. The results of this proposal will be
the first to reveal the kinetic differences in AKT activation as cells respond to pathological conditions, and can be
applied to any system. The prosed work over the next five years will generate substantial data and represents a
hypothesis generating platform to propel the field forward.

Public health relevance
Project Narrative The goal of this proposal is to dissect the molecular mechanisms that underlie AKT activation in disease. Specifically, we will dissect AKT’s conformational dynamics, membrane association, and interaction with protein partners under pathological conditions using a combination of luminescent-, BRET- and proximity labeling-based approaches. The results of this proposal will provide critical insight into how the pathway works and responds to pathological conditions, will identify new targetable AKT-protein partner complexes, and provide insight in the long-term to treat disease.